Administrative Core - Novel Therapeutics for FSHD

PROJECT SUMMARY
The Administrative Core A will be responsible for the planning, development, coordination, and overall
administration of the University of Massachusetts Medical School (UMMS) W ellstone MD CRC focused on
Facioscapulohumeral Muscular Dystrophy (FSHD). Center leadership will continue under Dr. Charles
Emerson at UMMS, Dr. Louis Kunkel at Children's Boston, and Kathryn Wagner at Kennedy Krieger, all
highly experienced research administrators and accomplished scientists. The administrative unit for Core A
will be located at UMMS, which has substantial resources, personnel and experience for management of a
P50 Center. Core A will be the administrative hub to manage all Center resources and communications and
carry out policies and procedures that establish an energized environment to enable effective communication
and collaboration among all the Center constituents, including investigators, trainees, FSHD patients and
advocacy groups, industry partners, NIH and the public. The Center will promote its mission through its
website, which disseminates information on Center activities, biomaterials and research, and through its
partnership with patient advocacy groups, particularly the FSH Society, which co-sponsors FSHD Research
W orkshops and Researcher-Patient Networking meetings to engage patients, researchers, trainees and NIH
in our Center mission. Through Core A, the Center will promote the distribution of muscle cell lines from its
W ellstone FSHD Cell Repository as a unique FSHD bio-resource. Internal committees will enable Center
leadership, investigators and trainees to effectively utilize resources, organize internal dataflow and
communications, and receive feedback on Center management, research progress and training. Regularly-
scheduled web conference meetings will focus on trainee and PI data sharing and research planning, and an
annual W ellstone Center Retreat at UMMS will bring investigators and trainees face-to-face with a Center
Advisory Committee (CAC) and NIH program leaders to review research progress, set goals and align Center
activities with the NIH W ellstone Center Network.